Using Multimodal Real-Time Assessment to Phenotype Dietary Non-Adherence Behaviors that Contribute to Poor Outcomes in Behavioral Obesity Treatment

PROJECT SUMMARY/ABSTRACT
Behavioral obesity treatment (BOT) produces clinically significant weight loss and reduced disease risk/severity
for many individuals with overweight/obesity. Yet, many patients fall short of expected outcomes, which can be
largely attributed to lapses from the recommended diet. Our work has shown that dietary lapses (specific
instances of nonadherence to the prescribed calorie target(s) in BOT) are frequent during weight loss attempts,
and are associated with poorer weight losses and higher daily energy intake. Despite the potential for lapses to
influence BOT outcomes and health, poorly understood variability in types of lapse behaviors and their
mechanisms interferes with our ability to intervene on them. In our research, participants have identified distinct
behaviors associated with lapse (e.g., eating an off-plan food, eating too large a portion of food). Across several
studies, we have established the concept of “dietary lapse types” (i.e., specific eating behavior(s) and contextual
factors underlying a dietary lapse). We have shown that behavioral, psychosocial, and contextual mechanisms
may differ across dietary lapse types, and that some lapse types appear to be more detrimental than others for
weight control. Elucidating clear dietary lapse types therefore has major potential for understanding and
improving adherence in BOT, but we have been unable to do so because our work is limited to secondary
analyses of data from larger trials that have incomplete measures of lapse types, potential mechanisms, and
clinical outcomes. We propose to extend our research by using behavioral phenotyping (i.e., data-driven
identification of underlying behavioral, psychological, and contextual factors of a health behavior) to establish
lapse phenotypes, and understand their impact on clinical outcomes. While typical phenotyping studies cluster
individuals via unique characteristics, we aim to understand phenotypes of lapses as a specific behavior within
individuals. We will use multimodal real-time assessment tools within a multi-level factor analysis framework to
uncover phenotypes while accounting for behaviors occurring within individuals and within days. Adults with
overweight/obesity (n=150) will participate in a well-established 12-mo. online BOT and 6-mo. weight loss
maintenance period. Participants will complete a 14-day lapse phenotyping assessment battery at baseline, 4,
8, 12 and 18 months. EMA and passive sensing tools (i.e., wrist devices, geolocation) will assess dietary lapses
and relevant phenotyping characteristics identified from our prior work. Participant energy intake will be assessed
with 24-hour dietary recalls and weight will be measured pre- and post- assessment. Results will yield a set of
lapse phenotypes and knowledge of their underlying mechanisms, which will can inform novel interventions to
improve dietary adherence in BOT (and in other treatments for which dietary adherence is critical). This
innovative approach will advance the science of adherence more broadly by supporting the development of
sophisticated theoretical models of adherence behavior and give rise to novel phenotyping methods that can be
leveraged to better understand and treat non-adherence to other health behaviors (e.g., medications, activity).

Public health relevance
PROJECT NARRATIVE Although dietary lapses (i.e., instances of non-adherence to dietary goals) are a major cause of poor outcomes during behavioral obesity treatment, poorly understood variability in types of lapse behaviors and their mechanisms interferes with an ability to intervene on them. Therefore, we propose to use multimodal real-time assessment of behavioral, psychosocial, and contextual information to uncover and validate lapse phenotypes (i.e., meaningful clusters of lapse behaviors, such as lapsing via overeating vs. lapsing via eating an off-plan food), and then validate these emerging phenotypes by testing their associations with weight change and energy intake. By applying a multi-level analysis approach to phenotype specific lapse behaviors clustered within individuals over time, this project will: a) support the development of sophisticated theoretical models of adherence behaviors, b) inform precision tools that improve dietary adherence in behavioral treatments for obesity, and c) establish novel phenotyping methods that can be used to understand and intervene upon non- adherence across a myriad of other chronic health conditions (e.g., diabetes, renal disease).